Entertainment-Education and Technology for Adolescent Sexual Health (EETASH)

PROJECT ABSTRACT
The Centers for Disease Control and Prevention (CDC) reported 26 million new cases of sexually transmitted
infections (STIs) in 2018, and nearly half were among youth ages 15-24. Additionally, while adolescent
pregnancies have declined over the past decade, rates remain higher in the U.S. than in other developed nations.
Compared to non-Hispanic White youth, Black and Latino youth (BLY) have higher rates of common STIs, of
HIV, and of unintended pregnancies. Among 13-24-year-olds diagnosed with HIV in 2021, 53% and 27% were
Black and Latino, compared to White (14%). Among 15-19-year-old Black and Latino youth in 2021, rates of
chlamydia were 5.5 and 1.2 times higher (3,929 and 846 per 100,000) than White youth (708), and rates of
gonorrhea were 11.9 and 1.4 times higher (1,610 and 188 per 100,000) than White youth (135). In 2018, births
rates among Black and Latina females (ages 15-19) were 26.3 and 26.7 per 1,000, compared to 12.1 among
White females. While prevention methods (e.g., condoms, non-barrier contraceptives, HIV PrEP, and STI/HIV
testing) are highly effective, BLY report addressable barriers (e.g., low awareness and risk perceptions, low self-
efficacy for condom negotiation, and confidentiality concerns). We propose developing a culturally-tailored, age-
appropriate, and engaging intervention that combines entertainment-education (EE) and mobile health (mHealth)
to increase STI/HIV testing and use of effective STI and unintended pregnancy prevention methods. This
intervention will include a 30-minute entertainment-education (EE) video with characters that model the healthy
behaviors as well as mHealth components that include additional skills-building videos; comprehensive
information about testing and prevention strategies; tools to help individuals and couples choose the right
prevention methods for them; and local resources to access sexual and reproductive health (SRH) services. The
entire program, including the video and technology elements, will be available in English and Spanish.
In Phase I, we will use human-centered design to develop EE and mHealth prototypes in English and Spanish
with high feasibility, acceptability, usability, and likely uptake among BLY and SRH service providers and staff at
organizations that would implement the intervention. Research activities will include: 1) conducting focus groups
(12 groups) with BLY and 12 interviews with SRH providers to develop initial EE storylines and mHealth
prototypes; 2) conducting multiple iterative rounds of rapid prototyping with BLY and SRH providers to develop
pre-final EE and mHealth prototypes; 3) testing pre-final prototypes in online surveys with BLY (n=200) and SRH
providers (n=25); and 4) making final refinements to the EE script using live table reads. In Phase II, we will fully
develop the intervention and conduct a randomized controlled trial to evaluate it. We will commercialize the
intervention by partnering with organizations, schools, universities, community clinics, and health departments
nationwide.

Public health relevance
PROJECT NARRATIVE The Entertainment-Education and Technology for Adolescent Sexual Health (EETASH) intervention combines a brief, engaging, and culturally and age appropriate entertainment-education video and a comprehensive mobile health (mHealth) website with to prevent sexually transmitted infections (STIs), including HIV, and unintended pregnancy among Black/African American and Hispanic/Latino youth ages 16-20. EETASH will promote routine STI testing and the use of research-supported effective STI prevention methods, such as condoms and HIV pre- exposure prophylaxis (PrEP), as well as effective contraceptive methods (including dual contraception). We will employ human-centered design in this Phase I SBIR project to develop mHealth and entertainment-education prototypes with high levels of feasibility, acceptability, usability, and uptake among Black/African American and Hispanic/Latino youth and sexual and reproductive health service providers who ultimately will implement the intervention.